Bone Loss and Immune Reconstitution in HIV/AIDS

Osteoporosis and bone fractures are established complications of HIV/AIDS and two of every three patients with HIV-infection are osteopenic or osteoporotic leading to a fracture incidence up to 4 fold higher in HIV patients over a wide age range. This is especially pertinent to men where fracture risk is typically low until advanced age. This substantial increase in fracture prevalence in relatively young adults is a significant public health concern as fractures can be debilitating and are frequently associated with devastating outcomes. With the advancing age of this population due to the success of antiretroviral therapy (ART), a synergy between HIV- and age-related skeletal decline could precipitate an epidemic of bone fragility disease. Another major conundrum in this field is that ART exacerbates rather than ameliorates bone loss. Interestingly, the skeletal effects of ART, though varied in magnitude, appear universal regardless of regimen. While a wealth of data now supports the notion of ART-induced bone loss, exactly when after ART initiation bone resorption begins and abates is unclear, and the underlying mechanism remains enigmatic. This dearth of knowledge has handicapped the design and implementation of strategies to limit further bone loss in patients who already exhibit an impoverished skeleton resulting from direct HIV assault. To begin to explore these issues, we recently examined bone turnover in patients initiating ART and documented a surge in bone resorption in virtually all patients starting as early as 2 weeks after ART initiation, peaking by 12 weeks, and remaining significantly elevated for up to at least 24 weeks. Importantly, T-cell recovery with ART reaches a significant magnitude at 12 weeks, the same time point at which this surge in resorption peaked, suggesting a possible link between immune recovery and ART-induced bone loss. In fact, it is now well established that bone remodeling, the process responsible for skeletal renewal, is strongly influenced by the immune system. This is the result of a deep integration and centralization of common cell types and cytokine mediators that we have termed the immuno-skeletal interface. Based on our preliminary data demonstrating that T-cell reconstitution in animals elicits a rapid and robust bone loss and our clinical studies demonstrating a temporal relationship between ART initiation, immune-reconstitution, and bone resorption, we hypothesize that immune- reconstitution, a consequence of ART-induced disease reversal, leads to robust, but acute, bone loss during the early period of ART. We propose 2 Specific Aims to further address this hypothesis: Specific Aim 1: To elucidate the mechanisms by which T-cell reconstitution drives skeletal deterioration; and Specific Aim 2: To demonstrate that skeletal deterioration associated with ART in humans, is a rapid, but relatively acute event, associated with T-cell reconstitution and immune regeneration, as a consequence of ART-induced disease reversal. These mechanistic studies into the pathophysiology of ART-induced bone loss will set the stage for future clinical studies to explore therapeutic approaches to preventing ART-induced bone loss.

Public health relevance
Project Narrative Osteoporosis is a well known complication of antiretroviral therapy (ART), but the mechanisms remain poorly defined. This proposal investigates novel hypotheses regarding therapeutic approaches to, and temporal and mechanistic aspects of, the skeletal deterioration associated with initiation of antiretroviral therapy (ART) in patients with human immunodeficiency virus 1 (HIV-1) infection/acquired immunodeficiency syndrome (AIDS). __SpecificAimsTextDelimiter__ Hypotheses and Specific Aims This proposal uses humans and animal models to investigate novel hypotheses regarding the temporal and mechanistic aspects of the skeletal deterioration associated with initiation of antiretroviral therapy (ART) in patients with human immunodeficiency virus 1 (HIV-1) infection/acquired immunodeficiency syndrome (AIDS). HIV-infection and Bone Loss: Osteoporosis and bone fractures are established complications of HIV/AIDS1 6 7 and two of every three patients with HIV-infection are osteopenic or osteoporotic8. Importantly, several recent studies show that fracture prevalence is up to 2- to 4-fold higher in HIV patients over a wide age range9 10 11. This is especially pertinent to men where fracture risk is typically low until advanced age. This substantial increase in fracture prevalence in relatively young adults is a significant public health concern as fractures can be debilitating and are frequently associated with devastating outcomes12 13. There are indications that this trend will escalate. With the advancing age of this population due to the success of ART, a synergy between HIV- and age-related skeletal decline could precipitate an epidemic of bone fragility disease14. ART and Bone Loss: Another major conundrum in this field is that unlike its effect on other HIV/AIDS related pathologies, ART exacerbates rather than ameliorates bone loss15. Interestingly, the skeletal effects of ART, though varied in magnitude, may be universal regardless of regimen16 and are typically documented within the first 1-2 years of therapy17 18,19. Studies routinely find a loss of up to 6% in bone mineral density (BMD) at the hip, a common site of bone fracture20 21. This loss is clinically significant, and of a magnitude comparable to that sustained over 5-10 years in postmenopausal osteoporosis, the archetypal bone disease of women22. Acuity of ART-induced Bone Loss: While a wealth of data now supports the notion of ART-induced bone loss, exactly when after ART initiation bone resorption begins and abates is unclear, and the underlying mechanism remains enigmatic. This dearth of knowledge has hindered the design and implementation of strategies to limit further bone loss in patients who already exhibit an impoverished skeleton resulting from HIV related depletion. To begin to explore these issues we recently examined bone turnover in patients initiating ART and documented a surge in bone resorption in virtually all patients starting as early as 2 weeks after ART initiation, peaking by 12 weeks, and remaining significantly elevated for up to at least 24 weeks. Importantly, T- cell recovery with ART reaches a significant magnitude at 12 weeks23, the same time point at which this surge in resorption peaked, suggesting a possible link between immune recovery and ART-induced bone loss. The Immuno-Skeletal Interface: In fact, it is now well established that bone remodeling, the process responsible for skeletal renewal, is strongly influenced by the immune system. This is the result of a deep integration and centralization of common cell types and cytokine mediators that we have termed the "immuno- skeletal interface". This includes lymphocytes, both T- and B-cells, which can promote bone resorption by secretion of the key osteoclastogenic cytokine RANKL, and of TNFα which synergizes with RANKL to amplify its activity. Further, B-cells also have the capacity to lower bone resorption by secretion of osteoprotegerin (OPG), a RANKL-decoy receptor and physiological suppressor of osteoclastogenesis24. As the immune and skeletal systems utilize common cell types and cytokine effectors, diseases associated with immune dysfunction, such as HIV-infection, have a significant potential to cause collateral skeletal damage. Indeed, our preliminary studies in an animal model of T-cell reconstitution clearly demonstrate the concept that T-cell regeneration induces rapid and robust bone resorption leading to a severe decline in skeletal integrity. Hypothesis: Based on our preliminary data demonstrating that T-cell reconstitution in animals elicits a rapid and robust bone loss and our clinical studies demonstrating a temporal relationship between ART initiation, immunereconstitution, and bone resorption, we hypothesize that immunereconstitution, a consequence of ART-induced disease reversal, leads to robust, but acute, bone loss during the early period of ART. Specific Aim 1: To elucidate the mechanisms by which T-cell reconstitution drives skeletal deterioration. We will use our animal modela of T-cell reconstitution/regeneration to extend our preliminary studies into a detailed mechanistic investigation of the immuno-skeletal interface, and the cells and cytokines involved in mediating bone loss in the context of T-cell reconstitution and immune regeneration in an immunocompromised animal. Specific Aim 2: To demonstrate that skeletal deterioration associated with ART in humans is a rapid but relatively acute event associated with T-cell reconstitution and immune regeneration as a consequence of ART-induced disease reversal. We will translate our preliminary studies in animals demonstrating the capacity of T-cell reconstitution to induced bone loss, into a clinical study in which we will investigate how T-cell reconstitution and immune reactivation drives skeletal deterioration in the context of ART-initiation. We will demonstrate that the preponderance of bone loss occurs uniquely within a defined window early (0 - 48 weeks) during ART therapy. These mechanistic studies into the pathophysiology of ART-induced bone loss will set the stage for future investigation to explore therapeutic approaches to preventing ART-induced bone loss.